Molecular and cellular characterization of the human brain across menopausal transition

Abstract
The menopausal transition (MT) spans, on average, 2-8 years before the final menstrual period and is associated
with significantly increased risk for major depressive disorder (MDD) and psychosis in women and other people
with ovaries. While ovarian hormone shifts are strongly implicated in the increased psychiatric risk, the underlying
biological mechanisms are unknown. Our previous studies in mice demonstrated that ovarian hormones
dynamically change neuronal chromatin organization and gene expression in the ventral hippocampus, and we
connected these molecular changes to changes in synaptic plasticity and anxiety-related behavior. Parallel
ovarian hormone-induced changes in brain structure and activity have been found in the hippocampus of both
mice and humans, but cellular and molecular studies in humans are lacking. Here, we hypothesize that the
anterior hippocampus (aHIP), the analogous brain region critical for emotion regulation in humans, undergoes
extensive changes in cellular composition and epigenome across the MT. We hypothesize that these changes
are largely hormonally-driven, and could unmask genetic risk for depression and psychotic disorders in
susceptible women. To address this question, we will work with a cohort of 42 postmortem human brains in
which we defined the menopausal and hormonal status based on 39 putative menopausal biomarkers. The
cohort includes three age groups: <40 years (“pre-menopausal”, N=10), 45-55 years (“peri-menopausal”, N=21),
and >55 years (“post-menopausal”, N=11), consisting of individuals with MDD/depression (N=18) and control
individuals or those without depressive symptoms (N=24). In Aim 1, we will perform single-nucleus multiome
analysis of the human aHIP in pre-, peri-, and post-menopausal subjects, in order to define cellular clusters,
gene expression, and chromatin states that shift in the aHIP across the MT. In Aim 2, we will perform Micro-C
analysis of neuronal and non-neuronal cells of the aHIP in order to examine the MT-associated changes in the
3D genome, including chromosome compartments, topologically associating domains, loops, and enhancer-
promoter interactions. Finally, in Aim 3, we will analyze the association of MT-sensitive gene regulatory regions
with genetic risk loci for depression and schizophrenia, providing molecular mechanisms underlying enhanced
psychiatric risk in women and other individuals undergoing MT. In summary, this project will allow us to
characterize cellular and molecular changes in the human aHIP across MT using high-resolution, cutting-edge
genomics techniques in uniquely curated brain tissue cohort. Our findings will open the path for the hormone
status-informed, precision medicine approach in women’s mental health.

Public health relevance
Narrative The menopausal transition is the midlife transition that precedes the final menstrual period, leading to complete cessation of ovarian function and reproductive senescence in women and other individuals with ovaries. During the menopausal transition, women show an increased risk for depression and psychotic disorders that is linked to changing levels of ovarian hormones. In this study, we will characterize cellular and molecular changes in the brain across the menopausal transition to gain a mechanistic insight into the increased psychiatric risk, facilitating novel precision medicine approaches in women’s mental health.